Basic Cardiovascular Research Training Grant

Despite decades of research there are still fundamental gaps in our knowledge of the underlying mechanisms
that contribute to development and progression of most cardiovascular (CV) diseases, as well as the end stage
clinical consequences of these diseases and how to better treat or prevent them. A central premise of this T32
Basic and Translational Cardiovascular Research Training Program (CVTP) is that these diseases are extremely
complex, and that rigorous study of them requires trainees to have a strong foundation of knowledge of basic
CV physiology, developmental biology, genetics, genomics, bioinformatics, epigenetics, pathology, systems
biology, biomedical engineering, and other disciplines. A major strength of our CVTP is that we have 40
outstanding clinical, translational, and basic science mentors representing these areas, and have built a unique
training program over the past several decades that integrates mentoring talents into producing the best trained
CV scientists possible. Our goal is to provide pre-doctoral and post-doctoral trainees the necessary knowledge,
intellectual capabilities, technical skills, passion, and problem-solving abilities to conduct outstanding state-of-
the-art CV research employing a wide range of powerful and innovative approaches. Support is requested for 8
pre- and 7 post-doctoral fellows who represent a small fraction of a much larger cohort of CVTP trainees who
are working in mentor laboratories. The program is led by co-PIs Drs. Gary K. Owens and Brant Isakson, as well
as two talented Associate Directors Drs. Coleen McNamara and Shayn Peirce-Cottler who are all exceptional
CV researchers and mentors. Pre-doctoral trainees are selected from a large pool of outstanding trainees initially
recruited into an umbrella biomedical sciences (BIMS) graduate program or the UVA MD/PhD (NIH MST)
Program, whereas post-doctoral candidates are largely recruited by individual mentor labs or from one of several
clinical residency-fellowship programs. After completing a highly innovative BIMS 6000 core course in integrated
biology in year 01, CVTP pre-doctoral trainees take elective modular courses that are customized based on their
interests and degree program. They also complete three lab rotations to aid in selection of a mentor. Only
trainees who have already selected a CVTP mentor are eligible for appointment. All trainees are required to take
our signature CVTP advanced courses including BIMS 8052-3 (Advanced Vascular Biology) and BIMS 8064 (a
trainee-run Careers/Professionalism Course), and are also required to attend our weekly research seminars,
monthly research in progress sessions, bi-annual research retreats, and to complete biomedical ethics training.
The CVTP also has an exceptional grant writing program including an annual workshop and approximately 20
annual grant brewing sessions. There are many indices of the success of this program including: 1) many former
CVTG trainees being leaders in their field; 2) current CVTG trainees publishing many high impact first author
papers and having a 48% success rate in securing extramural fellowships upon first submission; and 3) 90% of
trainees who have completed training the last 10 years have secured high quality permanent research positions.

Public health relevance
PROJECT NARRATIVE: In spite of decades of research and expenditure of billions of dollars, cardiovascular disease (CVD) remains the leading cause of death worldwide and is increasing in incidence as a consequence of global Westernization with subsequent epidemics in obesity, metabolic disease, and diabetes, all of which greatly exacerbate CVD. A central premise of this Basic and Translational Cardiovascular Research Training Program (CVTP) is that these diseases are extremely complex, and that rigorous study of them requires trainees to have a strong foundation of knowledge in basic CV physiology, developmental biology, genetics, genomics, bioinformatics, epigenetics, pathology, systems biology, biomedical engineering, and many other disciplines. The goal of this training program is to provide both pre- and post-doctoral trainees a highly integrated training experience to enable them to be facile in all of these disciplines thus uniquely enabling them to conduct pioneering studies of the pathogenesis of CVD, and to contribute to development of innovative and much more effective ways to treat or prevent them.